NESARC-III DNA STORAGE

This contract is for the continued safe and secure storage, and potential transfer, of the NIAAA DNA Repository of
24,223 DNA samples (38,786 aliquots) from the NESARC-III study at the Rutgers University Cell & DNA Repository (RUCDR)
III.